Center for Transformative Infectious Disease Research (CTIDR)

Some of the greatest human health impacts from infectious diseases are influenced by
weather events and seasons, which can shape when and where outbreaks occur,
influence the abundance of disease vectors, and affect the survival and transmission of
pathogens. Billions are at risk annually from rainfall-dependent malaria, and viral pathogen
spillover events and spread of vector-borne diseases (VBD) are increasing due to
extreme weather events. In response to these urgent threats, Cornell University has
created the Center for Transformative Infectious Disease Research (CTIDR). To
have the greatest health impacts, we must change research and practice paradigms from
reactive focus on response to outbreaks to proactive understanding of the complex social
and environmental conditions that promote risk of outbreaks. We hypothesize that
community-engaged research integrating human, reservoir and vector behavior,
weather, land-use, human and animal health, and vector/pathogen genomic evolution
datasets, will enable creation of predictive epidemiological models and future generation
and rigorous testing of preventative interventions. Improved understanding of these
relationships will also facilitate current preparation/response. Working toward these
goals, we integrate dimensions of building research capacity and performing
transdisciplinary research in every element of CTIDR. Administrative Core (Travis, PI):
will facilitate routine meetings; administer a pilot grant competition with preference for
Early-Stage Investigators (ESI) to generate preliminary data and test feasibility for future
studies; and organize transdisciplinary training for ESIs, post-doctoral and graduate
student trainees to broaden their skills and network for future predictive infectious
disease research. Living Evidence Applied Data Modeling Core (Hayden-ESI; SmithESI; Bento-ESI, co-leads): will integrate seemingly disparate datastreams spanning
different disciplines and leverage transdisciplinary modeling expertise to enable
researchers to combine weather, land-use, animal and human health, and genomic data,
thereby disentangling generalizable patterns from context-specific relationships in
disease dynamics. Community Engagement Core (Meredith-ESI, lead): will engage
with every project to enable/perform community-informed research that is relevant and
can effect long-term positive change. Project 1 (Plowright, lead): hypothesizes that
weather extremes and land use changes result in wildlife stress, increasing both viral
shedding and interaction with humans, facilitating viral spillover events (paramyxo-,
corona-, and filoviruses). Project 2 (Goodman-NI, lead): hypothesizes that an integrated
framework for a community-based early warning system for weather-sensitive VBD can
promote human health, building upon existing remote sensing with new focus on
mosquito-borne viruses and tick-borne pathogens (Anaplasma, Rickettsia, Coxiella),
including genomic analysis for hotspots of selection. Center function is supported by
world-class transdisciplinary research environments and institutional commitment to
community engagement and impact.

Public health relevance
OVERALL PROJECT NARRATIVE Extreme weather events greatly increase the risk that new viral diseases will spillover from animals into people, and greatly increase the spread of diseases carried by ticks or mosquitoes to new areas. Preventing the outbreak of disease before it occurs is the best way to protect the public’s health. Working with vulnerable rural communities who are most at risk, we propose to integrate social, biological and weather data into models that can predict when outbreaks occur, so that we can design interventions to prevent them.